Medical Scientist Training Program

Our University of Pittsburgh-Carnegie Mellon University MSTP prepares MD-PhD trainees with the expertise and
versatility to have highly productive careers as physician scientists and leaders in an evolving scientific and medical
environment. Students in our bi-institutional MSTP benefit from a world-class research and clinical community and a core
group of 158 well-funded mentors in 22 affiliated graduate programs in which prior MSTP trainees have thrived with a
62% F30 success rate and median of six publications over the last five years. Currently, our MSTP has 94 trainees, 55%
of whom are women and 15% from underrepresented backgrounds. Unique features of the MSTP include a required core
curriculum of seven courses beyond medical and graduate school coursework that build specific research, translational,
and professional competencies required for durable success as physician scientists. Training in rigor and reproducibility,
responsible conduct of research, and health equity are integrated throughout the curriculum and research and clinical
training experiences. Our faculty are also trained in these areas and engage in case-based workshops to learn and share
best-practices in mentoring MSTP trainees. Additional features include one-on-one executive coaching sessions for
students, each student's personal career advisor who serves as advocate, guide, and IDP reviewer from matriculation to
graduation and beyond, and the programmatic and intellectual integration of clinical and research training. Objectives
include: (1) Imparting transformational knowledge and thinking skills. We build students' ability to frame testable
hypotheses addressing significant research questions that can be linked to clinical knowledge and prepare trainees to plan,
conduct, analyze, and publish significant, rigorous high-quality, reproducible research and obtain funding to support it. (2)
Expanding trainee's toolkit. We position trainees to meet evolving challenges in health and disease as well as the demands
on the physician scientist workforce, preparing them for critical appraisal and use of new technologies and informatics. (3)
Building skills for forging productive partnerships. We train students to develop and refine ideas while engaging
stakeholders, work effectively in teams, communicate and learn from diverse audiences, and convey the joy of discovery.
In addition to measuring deliverables and career milestones as outcomes, we will test the ability of the program to build
student confidence in research self-efficacy and professional self-efficacy. Expert input is engaged for learning assessment
and strategic planning to allow our MSTP to remain dynamic and inclusive and adapt to the scientific landscape.

Public health relevance
At this time of unprecedented growth in scientific discovery and challenges to health, we plan to generate physician scientist leaders to meet the nation’s needs through a training program leading to dual MD and PhD degrees. The program draws on best practices in education and in launching and sustaining careers leading to major research advances and the translation of those discoveries to advance health and combat disease. We seek to train and equip academia, industry and other domains with a superlative and diverse cadre of MD- PhD graduates who will accelerate biomedical progress at the interface of research and clinical medicine.